Chemical Biology Approaches for Studying Circadian Rhythms

Project Summary/Abstract
Circadian clocks are time-tracking systems that allow organisms to adapt to the time of day, and drive many
cellular functions. Their alteration can lead to various diseases, including cancer, heart disease, and metabolic
disorders. In this work, we propose development of a chemical biology toolbox, consisting of both imaging and
protein-targeting platforms to facilitate studies of circadian rhythms at the molecular level that have otherwise
not been possible. The core clock is comprised of a transcriptional-translational feedback loop with multiple
protein components, including paralogs. Disparities have been observed between promoter activity and protein
translation, among responses of core clock components to stimuli, and compensatory mechanisms resulting
from knock-down and knock-out strategies. To address these gaps and facilitate additional studies of the
molecular clock, we will use chemical biology-based strategies to: 1.) generate orthogonal chemiluminescent
scaffolds to track promoter activity and protein translation of multiple circadian genes in a parallel, high-content
manner; and 2.) develop small molecule and protein-based tools to directly target circadian proteins and their
interactions.
For studies of the molecular clock, it is essential to track circadian rhythms and target core clock proteins in a
dynamic and selective manner. Firefly luciferase-based reporters have been used to assess promoter activity of
individual circadian genes, and most protein-based studies involve cells derived from a single luminescent
mouse model. We will use orthogonal chemiluminescent probes (Nano-lanterns) to develop a multi-signal
platform to simultaneously track and associate promoter activity and protein translation relationships among
multiple genes. Perturbation of circadian proteins is also essential for understanding mechanisms, including
paralog roles. Currently, there are few options outside of genetic approaches, which can result in unilateral
changes and activation of network compensation mechanisms. Molecular tools offer the ability to directly target
the functional components of the clock – proteins, and/or their interactions. While small molecules present an
attractive approach, relatively few exist that directly target core clock proteins. Hence, we propose to generate
new agents for interrogating the circadian clock system: we will repurpose validated clock protein-binding small
molecules by synthetically converting them into protein degraders (PROTACs), and use yeast surface-display to
identify nanobodies that bind circadian proteins and prevent specific interactions. Together, these approaches
present a powerful means to understand the mechanisms of the circadian clock, and can be used in a variety of
models and in studies of diseases, including to uncover new therapeutic targets.

Public health relevance
Project Narrative Circadian clocks are time-tracking systems that allow organisms to adapt to the time of day, and drive many cellular functions; their alteration can lead to a variety of diseases and physiological conditions. We propose the development of a chemical biology toolkit that will enable the concurrent tracking of multiple circadian signals at different levels, and utilize chemical entities to selectively target and alter the behavior of core clock proteins. These platforms will facilitate an array of further studies to understand the roles and functioning of the molecular clock that are currently not feasible.